Using Open-Source Technology to Measure Energy Expenditure and Sleep Among Children 3 to 8 Years Old

Assessing children’s 24-hour movement behaviors (i.e., time spent active, sedentary, and asleep) can reveal
the complex and interdependent ways energy expenditure and sleep are related to health outcomes. However,
assessing energy expenditure and sleep among children in free-living conditions is inherently difficult, and no
single method is without limitation. A combination of heart rate and accelerometry data provides a more precise
estimate of energy expenditure and sleep than either heart rate or accelerometry alone, when compared to a
criterion measure of indirect calorimetry or polysomnography, respectively. Yet, devices that measure both heart
rate and acceleration (such as ActiHeart or Fitbit) were not designed for children and may be distracting or
uncomfortable. Moreover, nearly all devices use proprietary algorithms and do not allow access to raw signal
data, and thus, are fundamentally unverifiable.
Our study team has developed the PATCH, a small, open-source wearable device which integrates multiple
sensors to measure heart rate and acceleration among children. The proposed project leverages the initial
PATCH calibration progress and extends this work to conduct a series of studies to establish the validity of the
PATCH to measure children’s energy expenditure and sleep in both laboratory and free-living conditions. The
objectives of the proposed project are (1) develop estimates of energy expenditure for children aged 3-8 years,
(2) measure sleep, compared to criterion polysomnography and (3) validate PATCH estimates of energy
expenditure and sleep in 24-hour free-living contexts. Our long-term goal is to advance the measurement field
for epidemiologic- and intervention-based studies that measure energy expenditure and sleep in the context of
free-living 24-hour movement behavior.
This project is innovative because it leverages off-the-shelf hardware and open-source processing. This means
that results from this project will enable other researchers to build their own PATCH device and independently
process the data, thereby overcoming issues related to proprietary hardware and algorithms that currently limit
the field of wearable devices. This project is significant because this technology has the potential to substantively
improve measurement of 24-hour movement across development in epidemiological studies and improve wear-
time compliance, given the PATCH’s small, unobtrusive design. Thus, this technology has promise to serve as
a powerful assessment tool for evaluating children’s free-living energy expenditure and sleep in observational
and intervention studies.

Public health relevance
The combination of heart rate and accelerometry provides better estimates of energy expenditure and sleep compared to either metric alone, but current wearable devices that measure both heart rate and acceleration are not designed for children and may be distracting or uncomfortable. Furthermore, current wearable devices use proprietary processing techniques, which means they cannot be truly validated. Therefore, our research team has created and calibrated an open-source wearable PATCH device designed to measure heart rate and acceleration among children 3-8, and the current project will develop and validate open-source algorithms to predict energy expenditure and sleep among children in both laboratory and free-living contexts.